Characterizing the role of sleep brain dynamics in the emergence of depression in adolescents

PROJECT SUMMARY
Adolescent onset of major depressive disorder (MDD) is a major public health concern causing greater risk for a
chronic and recurrent depression course, and an increased risk for suicide. Offspring of parents with a history of MDD are
at particularly high risk for developing depression. As depression rates among adolescents have been steadily rising in the
past decade, research on the discovery of biological markers of youth depression onset, particularly among highly vulnerable
populations, is crucially needed to develop early interventions targeting malleable factors. Sleep changes are a hallmark of
depression emergence, with sleep disturbances and changes in sleep architecture serving as a precursor to depression onset
in youth. Adolescents show high rates of poor sleep and strong vulnerability to emotional dysregulation driven by poor
sleep. This is paired to youth cortical neurodevelopment being crucial to emotional regulation, and signatures of sleep brain
dynamics changing in parallel with neurodevelopment. While current research shows associations between depression and
subjective sleep complaints, these studies rely on subjective measures and are mostly cross-sectional investigations, which
limits information on causal mechanisms of MDD emergence in youth. One promising objective marker of sleep
disturbances linked to adolescent depression is altered sleep brain oscillations. Specifically, youth with MDD show
increased frontal slow wave activity (SWA) and reduced frontal sleep spindles. Furthermore, high risk (HR) youth of
depressed mothers show changes similar to those found in MDD, albeit less pronounced, suggesting that these sleep profiles
may represent the substrate of a biological vulnerability that precedes the development of depression. This imbalance in
sleep oscillations is functionally relevant, as cortical Slow Oscillations (SOs, dynamic contributors to SWA), spindles, and
their coordination are associated with health, restorative properties of sleep, cognitive processing, average intelligence, and
brain homeostasis. However, there is currently no data on the predictive potential of quantifiers of sleep oscillations in
depression emergence in youth. Furthermore, recent work from PI Malerba introduced novel space-time analyses of SOs
and spindles enabling enhanced understanding of their biophysics and coordination. Since these properties are crucial to SO
and spindle functional roles, structural changes in SOs and spindles related to MDD risk in youth could inform on
mechanisms of depression emergence and novel targets for intervention. The proposed study will: (Aim 1) identify the
space-time profiles of SO and spindles, and contrast-compare the resulting properties across 92 youth at high and low risk
for depression; then (Aim 2) establish the predictive role of these space-time profiles in relation to increases in depression
symptoms at 3 and 6 months, and finally (Aim 3) explore the potential mediating role of emotional regulation in the relation
between sleep profiles and depression trajectories in youth. These findings will inform future research on early detection of
MDD in youth and the development of interventions that can manipulate these oscillations in youth with MDD.

Public health relevance
PROJECT NARRATIVE Adolescent onset of major depressive disorder (MDD) is a major public health concern causing greater risk for a chronic and recurrent depression course, and an increased risk for suicide; underscoring the need for research on the discovery of biological markers of youth depression onset, particularly among highly vulnerable populations, to develop early detection and intervention strategies. Sleep changes are a hallmark of depression emergence, with sleep disturbances serving as a precursor to depression onset in youth, and an imbalance in sleep brain oscillations tied to health and cognition found both in youth with MDD and at high risk for MDD, suggesting that these sleep profiles may represent the substrate of a biological vulnerability that precedes the development of depression. The proposed research will study the relation between sleep oscillations and increases in depressive symptoms in youth at high and low risk for depression, and explore the mediating role of emotional regulation in these associations, to gain insight into the predictive potential of sleep oscillations in depression emergence in youth and mechanistic elements that can become targets for modifications in future interventions.